COVID-19: NIAID SPECIMEN REPOSITORY

This contract provides critically needed comprehensive services related to operation of the NIAID Specimen Repository (NSR), and it will continue to help (1) secure, receive, catalog, process, aliquot, store, and disburse human biological specimens from subjects participating in NIAID-sponsored cohort studies and clinical networks (2) provide adequate cold storage facilities, (3) remain current on novel procedures for optimized storage of clinical specimens and be able to use state of the art technology to ensure specimen integrity from receipt to storage in the freezers and from freezers to shipment containers for outgoing shipments, (4) provide (or utilize the current) computerized Specimen Inventory Database Management System (SIDMS) that supports the repository's functions, and (5) develop, perform, and maintain Quality Assurance (QA)/Quality Control (QC) Program for the NSR facility, operations, stored biospecimens, shipping materials, and personnel in accordance with all applicable Federal, State, and local regulatory requirements. This project will provide support for the storage of samples from NIAID-sponsored SARS-CoV-2 (COVID-19) clinical studies.